Engineered Cytokine-Secreting Bacteria to Treat Periodontitis.

PROJECT
SUMMARY.
Periodontitis is one of the most prevalent diseases and a leading cause of tooth loss. In the United States,
approximately 61 million adults over 30 years old have periodontitis (42.2%) with 7.8% having severe
periodontitis. A disproportionate host response and dysbiotic microbiota are the two major etiologic factors. The
standard treatment, mechanical debridement, to remove biofilm has limited clinical efficacy in patients with
dysregulated immune responses. There is a critical need for novel host modulation therapies with safe, localized,
and effective delivery characteristics to treat periodontitis. Recent advances in synthetic biology have presented
new opportunities to use genetically-engineered bacteria for disease treatment. In particular, our team has
developed genetic tools to program the commercial human probiotic Limosilactobacillus reuteri (L. reuteri) to
secrete anti-inflammatory cytokines to treat inflammatory bowel diseases. Furthermore, we have increased the
viability and efficacy of these engineered L. reuteri by encapsulating them in biocompatible biomaterials. These
novel biotechnological approaches can be effective in treating periodontitis. The goal of this project is to develop
a biomaterial-enhanced system for targeted localization of engineered microbes releasing therapeutic
molecules, an “oral micro-drug factory”, effective for host modulation and tissue healing. Our objective is to locally
administer engineered L. reuteri secreting the anti-inflammatory cytokine, interleukin-10 (IL-10), to evaluate the
phenotypic and molecular effects in experimental periodontitis models. The hypothesis is that localized and
sustained delivery of IL-10 from well-contained L. reuteri can reduce periodontal inflammation and promote
periodontal tissue healing. We will achieve our goals through two specific aims: (1) Validate the ability of
engineered L. reuteri producing IL-10 to treat experimental periodontitis; (2) Use a microneedle patch to localize
L. reuteri and enable boosted potency delivery of IL-10 to treat specific areas of experimental periodontitis. Well-
established methods will be used to analyze local and systemic immune responses and oral microbiota shifts in
these periodontitis-affected animals treated with this novel approach. The outcomes of this project will
demonstrate that localized host modulation through the biomaterial-based application of engineered L. reuteri
can treat experimental periodontitis. Encapsulation of bacteria in the stable and biocompatible microneedle patch
attached to the gingiva will improve their effectiveness without allowing L. reuteri to become the dominant oral
species. This will shed light on novel clinical applications of engineered microorganisms able to achieve
localized, sustained host modulation in treating periodontitis using a combinatorial strategy of biomaterials and
synthetic biology.

Public health relevance
Project Narrative Periodontitis, one of the most prevalent oral diseases, is a leading cause of tooth loss, but standard mechanical debridement cannot effectively treat patients with severe periodontitis. This project aims to develop engineered cytokine-secreting Limosilactobacillus reuteri encapsulated in a microneedle patch to treat periodontitis in preclinical models. The results will advance the applications of engineered microorganisms combined with novel biomaterials in treating periodontitis through host modulation.